(2/2) Log2Lose: Incenting Weight Loss and Dietary Self-Monitoring in Real Time to Improve Weight Management

In the past 40 years, the prevalence of obesity has increased at an alarming rate. Even modest weight loss of
at least 5% improves clinical parameters and quality of life. Efficacious behavioral weight loss programs teach
participants behavioral strategies to create and maintain a caloric deficit. The two strongest predictors of long-
term weight loss in such programs are initial weight loss and dietary self-monitoring. Over time, these
phenomena decline, limiting program effectiveness. Financial incentives to increase initial weight loss and self-
monitoring are appealing because they can be delivered to large populations with relative ease and at low cost.
Employers and payers have begun to provide financial incentives for health behaviors and outcomes despite
an inadequate evidence base to inform the optimal design of such interventions. The proposed study will
evaluate which incentive approach has the greatest impact and durability—incentivizing interim weight loss,
dietary self-monitoring, or both. Studies testing the effects of incentivizing these phenomena have showed
some promise for increasing short-term weight loss, but the effects have not been sustained. Furthermore, few
studies have evaluated incentive effects on long-term weight loss; examined the mediating role of intrinsic or
extrinsic motivation; or calculated program costs or cost-effectiveness of financial incentive interventions. In the
proposed two-site, randomized, single-blinded, longitudinal 2x2 factorial study, known as “Log2Lose,” we
address these limitations by evaluating the individual and joint effects of incentivizing, in near real-time, interim
weight loss and dietary self-monitoring on 6-month weight loss and subsequent weight loss maintenance.
People with obesity from the communities of Madison, WI and Durham, NC will receive an 18-month
intervention comprising: 1. An incentivized weight loss program for 6 months (Phase I), 2. An incentivized
weight maintenance program for 6 months (Phase II), and 3. A non-incentivized weight maintenance program
for 6 months (Phase III). Participants will be randomized to receive adjunctive incentives for weekly weight
loss, dietary self-monitoring, both, or neither. We will measure the proportion of participants achieving clinically
significant weight loss of ≥5% at 6 (primary endpoint), 12, and 18 months. We will assess whether extrinsic and
intrinsic motivation mediate intervention effect; calculate intervention costs; and calculate cost-effectiveness
ratios across the four study arms. Our financial incentives intervention was designed to be scalable by using
available technology and automating the process of analyzing data to provide incentives in near real-time. The
intervention could be paired with various weight loss interventions offered by clinicians or payers, or integrated
into a variety of patient and consumer-facing technologies. Completion of this study will contribute to our long-
term goal of identifying and implementing efficacious, cost-effective, scalable approaches to reduce the
prevalence of obesity and associated health outcomes.

Public health relevance
Log2Lose is a clinical trial that seeks to evaluate whether people lose more weight when they receive small financial incentives for weekly weight loss or diet logging. Study software collects and analyzes weight data from a cellular-connected scale and dietary data from a smartphone dietary application ('app'). Algorithms analyze these data to determine if participants meet the criteria to receive an incentive. Participants receive a text message about whether they earned an incentive, and, if so, receive payment on a debit card.